A Developmental Framework For Linking Phonological And Morpho-syntactic Sequential Pattern Rules In Developmental Language Disorder

Abstract
A hallmark of English-learning children with developmental language disorder (DLD, AKA specific
language impairment) is the inconsistent production of grammatical morphology. However, recent work also
implicates the phonological domain, as indicated by deficits in producing word and nonword forms. The
hypothesis driving the current proposal is that morphological and phonological deficits are causally linked by a
broader deficit in sequential pattern learning. The unique approach taken here combines what we already
know about morpho-syntactic deficits in DLD with recent developments in the fields of linguistics and language
acquisition. First, it is possible to divide phonological and morphological patterns into three pattern types
(Single Feature, OR/Disjunction, Family Resemblance/Prototype), with these types having a long history of
study in visual pattern learning. Importantly, children with DLD appear to have maximum difficulty with morpho-
syntactic patterns of the OR type (e.g., regular past tense). In contrast, studies using artificial grammars show
that infants who are typically developing are highly adept at learning Single Feature and OR pattern types;
Family Resemblance patterns may be weaker. Typical adults are adept at Single Feature and Family
Resemblance patterns, but appear to be, at least superficially, more like children with DLD in their performance
on the OR pattern.
With these intriguing findings as a starting point, the proposed research links phonological and
morphological sequence learning in children with DLD. In Aim 1, we ask if 4- to 6-year-olds (typically
developing (TD), DLD alone, DLD + speech sound disorder (SSD), and SSD with no morpho-syntactic deficit)
and adults are sensitive to input examples that fit one of these three patterns. We predict that, consistent with
their long-documented morpho-syntactic deficit, children with DLD will have particular difficulty with the
phonological OR pattern. Consistent with their intact morpho-syntactic skills, children with SSD should show no
deficits in the OR pattern, revealing a link between OR pattern learning, phonology, and morpho-syntax. Aim 2
explores whether the inclusion of a semantic subcategory cue facilitates learning the OR pattern. Aim 3 asks if
dependence on the associatively organized lexicon can account for the infant-to-adult developmental changes
observed for the OR pattern (which is not associatively organized) and thereby explores the possibility that
children with DLD rely on their lexicons to compensate for their sequential pattern learning deficit. The results
of the proposed studies promise to help identify the underlying mechanism(s) of DLD and to suggest possible
intervention strategies, such as employing semantic cues to the OR pattern and strengthening lexical
organization.

Public health relevance
Project Narrative Developmental language disorder (DLD; AKA specific language impairment) results in poor academic and social outcomes and affects 7% of young school age children. Grammatical deficits are hallmarks of this disorder, though sound pattern learning (which emerges in infancy) underlies both grammatical and word learning difficulties experienced by these children. By linking sound pattern learning to both grammatical and word learning deficits, this research will potentially contribute to the earlier identification of children with DLD and also provide new avenues of treatment, and thus is consistent with the mission of the NIH.